NEUROPHARMACOLOGIC CHALLENGES IN DEMENTIA

The role of glutamate upon cognition will be examined by comparing the effect of intravenous ketamine on psychometric performance and behavior in patients with Alzheimer's disease, Huntington's disease, and age- matched normals. A better understanding of the effects of NMDA antagonists will help determine if therapies affecting these systems are likely to be beneficial.